Metabolic syndrome, chronic inflammation, and gout: a multi-omics approach

Gout, an inflammatory arthritis affecting 9 million US adults, is characterised by painful flares, joint damage,
and premature mortality. Gout frequently coexists with the metabolic (insulin resistance) syndrome (MetS) and
its cardiometabolic sequalae, but the nature of these associations remains controversial. It is also unclear what
modulates the progression from prolonged hyperuricemia (HU) to clinical gout, though emerging ‘omics data
have implicated genes and metabolites associated with inflammation. As such, multi-omics integration
(genomics, transcriptomics, metabolomics, and proteomics) could advance understanding of gout disease
mechanisms via a systems epidemiology approach. To comprehensively investigate the relationships between
MetS, chronic inflammation, and gout, I propose to examine 3 Specific Aims by leveraging the rich resources in
UK Biobank, Nurses Health Studies (NHS), Health Professionals Follow-Up Study (HPFS), and Genotype-
Tissue Expression project (GTEx). In Aim 1 [K99] I will integrate genetic association (GWAS) data from UK
Biobank, NHS/HPFS, and global consortia (including a new gout GWAS), and transcriptomic data in GTEx, to
examine shared genetic architectures between MetS components, systemic inflammatory markers, and gout,
and whether polygenic susceptibility to MetS and chronic inflammation confers gout risk. In Aim 2 [R00], I will
integrate existing dietary and metabolomic data to examine metabolomic profiles mediating the associations
between dietary hyperinsulinemic and inflammatory potentials, and HU and gout risk in the NHS/HPFS. In Aim
3 [R00]
I will conduct plasma proteomic profiling in a nested case-control study within NHS/HPFS to identify
inflammatory protein networks in relation to gout risk, and as a Secondary Aim, integrate findings from Aims 1-
3 to explore gout-related pathways co-regulating at multiple biological dimensions. This innovative project
should generate novel mechanistic insights into the metabolic and inflammatory pathways underlying HU and
gout risk, which could inform prevention and treatment; for example, whether improving metabolic syndrome
would reduce gout risk. Simultaneously, I will receive extensive training in gout systems biology and cutting-
edge, high-dimensional data analytics and bioinformatics, including machine-learning methods. I will be
mentored/advised by an interdisciplinary team at Mass General Hospital and Harvard including Dr. Hyon Choi
(gout epidemiologist), Dr. Liming Liang (expert in statistical ‘omics methodologies), Dr. Tony Merriman (gout
geneticist), Dr. Jessica Lasky-Su (expert in metabolomics and multi-omics integration), and Dr. Robert
Gerszten (proteomics expert). The outstanding and diverse training opportunities with key leaders in these
areas will provide me with advanced knowledge and skills, positioning me for a successful, independent career
applying systems biology and integrated ‘omics approaches to the study of gout and other complex traits. This
project aligns closely with NIAMS’ scientific objective to develop machine learning methods, combining layers
of ‘omics data, to generate new mechanistic hypothesises for gout and other systemic rheumatic diseases.

Public health relevance
NARRATIVE Gout is an increasingly common, costly, and painful inflammatory condition which frequently co- exists with the metabolic (insulin resistance) syndrome and its cardiometabolic sequalae, but fundamental questions remain about what drives its development and the progression from asymptomatic hyperuricemia to clinical gout. This Pathway to Independence Award will focus on applying a multi-omics approach, integrating genomics, transcriptomics, metabolomics, and proteomics, to comprehensively investigate the relationships between metabolic syndrome, chronic inflammation, and gout. This rigorous, cutting-edge approach, leveraging large genome- wide association studies, prospective cohorts with decades of follow-up, and rich dietary and biorepository data, will provide novel insights into gout disease mechanisms (e.g., genetic variants and metabolic and inflammatory pathways), thereby laying a foundation for new strategies to treat and prevent gout and its cardiometabolic comorbidities.